Modeling drugs of abuse-HIV interactions using iPSC-derived human cerebral organoids

Summary
HIV-infected microglia release cytokines, chemokines and viral gene products, such as gp120 and tat, that
are toxic to neurons. In this proposal, we will use human induced pluripotent stem cells (iPSCs) to generate
cortical and dopaminergic neurons as well as microglia, which will be cultured as organoids to model HIV-drug
abuse interactions in conjunction with in-depth genomic approaches and electrophysiology. We show
electrophysiological results that demonstrate that the levels of differentiation of the neurons in our organoids
are comparable to in vivo and ex vivo preparations and are among the best that can be found in the scientific
literature. To identify candidate host regulators of HIV expression and mediators of HIV-induced tissue damage
and disease progression, we will expose microglia-containing cerebral organoids to methamphetamine
(METH), a stimulant, and morphine, an opiate, which are members of two of the classes of drugs of abuse that
are more prevalent among People Living with HIV/AIDS (PLWHA). Cerebral organoids will be exposed to toxic
HIV products such as Tat, gp120, drugs of abuse and combination antiretroviral therapy (cART). In some
experiments we will also incorporate iPSC-derived astrocytes into microglia-containing cerebral organoids to
test the role of astrocytes in neuroprotection and neurodegeneration. We will carry out single-cell gene
expression profiling of iPSC-derived organoids exposed to drugs of abuse, HIV products, and cART and we
will employ an advanced systems biology strategy to generate testable mechanistic hypotheses on the
pathogenesis of neurodegeneration and tissue damage in neuroHIV (Aim 1) and identify candidate regulators
of the LTR promoter that may shed light on the regulation of latency and reactivation of the HIV provirus (Aim
2). In preliminary studies, this computational experimental approach allowed us to identify candidate drivers of
gene expression changes associated with neuroHIV and neurodegenerative diseases, including Alzheimer’s
disease and drug and alcohol abuse. These findings support the overarching hypothesis that dissection of the
gene regulatory network of the central nervous system will pave the way for the identification of novel
mechanistic hypotheses and druggable targets to improve neuropsychological functioning of PLWHA and
substance abuse comorbidity.

Public health relevance
Public Health Relevance This proposal will use cerebral organoids derived from human induced pluripotent stem cells (iPSC) to model HIV interactions with drugs of abuse and combination antiretroviral therapy (cART). We will utilize convergent state-of-the-art electrophysiology, single-cell transcriptomics and a systems biology strategy to generate new mechanistic hypotheses on neuroHIV pathogenesis, HIV interaction with drugs of abuse and cART. Ultimately, this proposal will lead to novel therapeutic concepts to improve neuropsychological functioning in people with HIV and substance abuse comorbidity.